Repurposing misoprostol to prevent recurrence of Clostridium difficile infection

PROJECT SUMMARY: Clostridium difficile infection (CDI) is a leading nosocomial infection and the primary identifiable cause of antibiotic-associated diarrhea. It can lead to multiple CDI recurrences, sepsis, toxic megacolon, and death. Recurrent CDI (rCDI) complicates 20-30% of primary episodes of disease is associated with an increased risk of death (nearly 45,000 deaths per year) and a poor quality of life. While probiotics, new biologic therapies, and fecal transplantation have met with some success in breaking the cycle of rCDI, there remains a need for simple, safe, and cost-effective solutions to this problem. We have assembled three independent, converging lines of evidence that suggest the already FDA-approved drug misoprostol (a prostaglandin analog) as a candidate for preventing rCDI. First, there is an emerging epidemiologic association between the clinical use of inhibitors of prostaglandin (PG) synthesis and an increased risk for CDI. Second, we performed a Phenome-Wide Association Study (PheWAS) based on ICD-9 billing code and genotype data in a disease-agnostic cohort of ~40,000 patients. We used PheWAS to identify potential novel genotype-phenotype associations related to the SNPs in the genes for the targets of misoprostol (PGE2 receptors). This innovative analysis predicted a potential new indication for misoprostol to treat (or prevent) C. difficile colitis. Third, we obtained preclinical data from a mouse model of antibiotic-associated CDI that show misoprostol has beneficial effects against CDI. In order to take they key next step in translating these findings into the clinic, we are planning a phase II proof of concept study: A RANDOMIZED, DOUBLE-BLIND, PLACEBO-CONTROLLED TRIAL TO ASSESS THE EFFICACY AND SAFETY OF MISOPROSTOL IN THE PREVENTION OF FIRST RECURRENCE OF CLOSTRIDIUM DIFFICILE INFECTION IN ADULTS AGED 50 AND OVER. We propose three aims: (1) Evaluate the safety and efficacy of misoprostol for prevention of rCDI, by determining if misoprostol can modify the rate and severity of rCDI in adults ≥50 years of age during the first 8 weeks after standard oral vancomycin therapy is completed; (2) Determine the effect of misoprostol on the gut microbiome and metabolome, diarrhea occurrence/severity, and the development of anti-C. difficile toxin antibodies, in order to inform the design of future studies, and (3) Continue the clinical development of misoprostol to optimize its potential to impact clinical practice and rapidly affect human health. The successful completion of these studies could have rapid clinical impact in the prevention of rCDI infection. Additionally, the scope of this work goes well beyond initial clinical proof of concept and also includes elements of real-world translation including production of an optimized formulation of the drug, a Pre-IND meeting with the FDA to discuss bridging studies needed for 505(b)(2) approval, and conduction of preliminary bridging studies based on input from the FDA. 1

Public health relevance
NARRATIVE The bacterium Clostridium difficile is a major cause of antibiotic-associated diarrhea, a leading infectious disease in US hospitals, and it can cause multiple recurrences despite initially adequate treatment. This proposal builds on the results of a phenome-wide association study that identified a possible new indication for misoprostol, an FDA approved prostaglandin E1 analogue, in preventing or treating C. difficile colitis. Preclinical mouse data have validated this association, and we are now proposing to conduct a clinical trial to test the hypothesis that patients with a primary episode of C. difficile infection who are treated with misoprostol in addition to standard of care therapy will have a reduced rate of C. difficile infection recurrence compared to patients receiving standard of care only.